Maintenance of cellular memory through replication

SUMMARY
The ability to express different genes in different cell types is crucial to development of a
multicellular organism. This cell-­type specific gene expression relies on memory of
activation and repression of genes through successive rounds of cell division as the
organism develops from an embryo to an adult. An important component of the memory
of cellular identity is the cell’s chromatin state. To maintain a transcriptional program, the
cell has to maintain accessibility at active promoters and enhancers and occlusion at
repressed promoters and enhancers. However, the passage of replication forks during
every cell cycle obliterates cell-­type specific chromatin landscapes. Our overarching goal
is to determine how chromatin landscapes are sustained in spite of nucleosome dynamics
throughout the cell cycle, thus maintaining cellular memory. Here, we will use genomic
methods we develop(ed) to identify cellular mechanisms that maintain chromatin
landscapes despite the erasing effects of replication. We will pursue two lines of
investigations: First, we will identify how transcription factors find their binding sites after
being stripped from the DNA during process of replication. We have shown that
transcription factors are replaced by nucleosomes genome-­wide post-­replication. By
tracking transcription factor binding to DNA and DNA accessibility as a function of time
post-­replication, we will uncover the determinants of transcription factor site selectivity.
We will also study the effect of chromatin remodeler function in creating transcription
factor binding sites post-­replication. Second, we will elucidate cellular mechanisms that
maintain repressed chromatin landscapes through replication at epigenetically silenced
domains that are characterized by trimethylated histone H3 (H3K27me3), which we call
“Polycomb domains”. Polycomb group proteins maintain repressed states at these
domains. Mechanisms that carry memory of repression through replication have to act
within a single cell cycle, every cell cycle. We will combine tracking chromatin states
genome-­wide post-­replication with carefully chosen perturbations of Polycomb group
proteins to uncover mechanisms that maintain this repressed state through replication.
Taken together, these studies will not only resolve long-­standing questions in transcription
factor-­site selectivity and Polycomb repression, but will also serve as a framework to
understand how chromatin dynamics can shape genome function in many biological
contexts.

Public health relevance
PROJECT NARRATIVE A cell’s identity is tied to how its genome is packaged. This cell type specific genome packaging is essential for normal development of the organism and is frequently disrupted in disease. This proposal will identify how a cell remembers the specific packaging of its genome every time it replicates its genome so as to maintain its identity during normal growth and how perturbation of this memory can lead to aberrant cell states.